Center of Research Excellence in Natural Products Neuro*

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To develop a pharmacology core to screen natural products and identify those with the potential for new therapeutics for central nervous system disorders.